Mechanism of dysbiosis caused by AE Pathogens

? DESCRIPTION (provided by applicant): Attaching and effacing (AE) pathogens are an important cause of diarrheal disease in both high-income and low-income countries. AE pathogens use an outer membrane adhesin, termed intimin, to bind to a receptor protein, termed translocated intimin receptor (Tir), which the pathogen injects into epithelial cells using type III secretion system (T3SS). The resulting intimate attachment to epithelial cells provides AE pathogens access to a microenvironment that boosts their growth through unknown mechanisms. This results in changes in the composition of gut associated microbial communities that are characterized by a dominance of the AE pathogen. The question of which mechanisms are responsible for these changes in the microbiota composition represents a high-impact topic that will be addressed in this application. Our central hypothesis is that T3SS-mediated intimate attachment to host epithelial cells provides AE pathogens with access to oxygen for respiration, thus providing a substantial advantage over fermenting commensal bacterial and driving dysbiosis in the gut. We will test different aspects of our hypothesis by investigating the mechanism by which the C. rodentium T3SS promotes aerobic respiration (Aim 1) and determining the consequences of aerobic respiration during competition of C. rodentium with the gut microbiota (Aim 2). The proposed work is innovative because it is among the first to elucidate molecular mechanisms that control the balance between AE pathogens, the host and its microbiota. It is our expectation that successful completion of the proposed work will usher in a major conceptual advance by demonstrating that intimate attachment to epithelial cells confers a fitness advantage by providing AE pathogens with access to oxygen for growth.

Public health relevance
PUBLIC HEALTH RELEVANCE: Attaching and effacing (AE) pathogens are an important cause of diarrheal disease in both high- income and low-income countries. Our large intestine is host to a large microbial community that provides benefit to the host by providing niche protection against colonization with potentially harmful bacteria. However, AE pathogens use their virulence factors to edge out the beneficial gut-associated microbial communities during infection through unknown mechanisms. Here we will elucidate the mechanism that enables AE pathogens to rise to prominence within the community during infection, which will usher in important conceptual advances that have a strong potential to exert a high impact on this field of science.